106th Annual Educational and Training Seminar

PROJECT SUMMARY/ABSTRACT
The objective of the 106th Annual CASA Educational and Training Seminar is to provide a venue where
field inspectors, food program managers, industry leaders and academia from across the region can
personally interact and share ideas while receiving information on current and emerging food topics
impacting health and safety. The agenda includes presentations that will give local and state regulators
an opportunity to hear a national and international perspective on food safety and will include emerging
hot topics such as the use of AI to improve food safety, the FDA’s food traceability rule, shellfish
sanitation and regulating “pop-up” restaurants. The agenda included in the Conference Plan contains
the list of topics to be presented at the conference.
To our knowledge, this is one of the most comprehensive and cost effective in-person educational
opportunities to address a range of current food safety issues facing state and local regulatory
programs. CASA maintains the cost of the conference as low as possible in an effort to allow access to
the seminar to the widest range of participants. The low cost of the conference enables food safety
professionals from all levels of the regulatory community and industry to participate.
The training will be held at the Hilton Richmond Hotel in Richmond, VA from May 6, 2024 - May 9, 2024
and 125 participants are anticipated. The conference draws representatives of state, county, municipal
and federal regulatory agencies charged with public health and safety responsibilities, the regulated
industries and university and research institution professionals.
The conference will contribute to a more educated, informed, and integrated food regulatory
community and this in turn will contribute to a safer food supply.

Public health relevance
PROJECT NARRATIVE The objective of the 106th Annual CASA Educational and Training Seminar is to provide a venue where field inspectors, food program managers, industry leaders and academia from across the region can personally interact and share ideas while receiving information on current and emerging food topics impacting health and safety. The conference will contribute to a more educated, informed, and integrated food regulatory community and this in turn will contribute to a safer food supply.